Brain Circuitry of Inhibitory Control: Effects of Modulation

Project Summary/Abstract
This COBRE project aims to delineate and modulate the response inhibition network in young adults with a
range of inhibitory control (IC). Inhibitory control is impaired in a va​ riety of clinical disorders, including
substance abuse, OCD, and ADHD. Def​ icits in response inhibition are likely related to development of certain
clinical disorders, poor treatment response, and relapse to a symptomatic state. T​ he goals of the proposed
study are to 1) characterize the neurocircuitry of the IC network (right inferior frontal gyrus (IFG),
pre-supplementary motor area (pSMA), subthalamic nucleus (STN)) in healthy young adults with a range of
scores on a widely-used clinical measure of inhibitory control (BRIEF-A Inhibit subscale) using task-based
(stop signal task) functional neuroimaging, 2) modulate the IC network through 2.0 mA anodal HD-tDCS to the
right IFG, and 3) test the hypothesis that the functional state of the IFG and the related IC network is related to
SST performance. Using a symptom-targeted approach as detailed in this proposal will lay the groundwork for
personalization of treatment. In this case, there are a variety of disorders in which inhibitory failure is common,
and there is tentative evidence that these disorders may share underlying pathophysiology in relevant
neurocircuits. Ultimately, greater understanding of this neurocircuitry may lead to new and improved more
individualized neurocircuit-based treatments based on common phenotypic presentations rather than on our
relatively unspecific diagnostic categorizations.

Public health relevance
Inhibitory control is relevant to many clinical disorders, including substance abuse/dependence, obsessive- compulsive disorder, and attention-deficit hyperactivity disorder. This proposal is designed to assess brain networks related to response inhibition in healthy young adults, and use neuromodulation to change these networks and behavioral performance on a response inhibition task. Having an understanding of the brain mechanisms involved in response inhibition may enable us to improve pre-existing treatments for disorders with inhibitory control difficulties.